Emory Specialized Center of Research Excellence (SCORE) on Sex Differences

PROJECT SUMMARY / ABSTRACT (Project 3: Heart)
Persistent inflammation and immune dysregulation play a pivotal role in the early onset of cardiovascular
disease (CVD) in HIV. Among women living with HIV (WLH), CVD risk is further compounded by estrogen
deficiency and early menopause that have a significant impact on the gut, by inducing dysbiosis from
disruption of the gut integrity, leading to microbial translocation and systemic inflammation that in turn
promotes vascular disease and its progression.
In the Emory SCORE tripartite Bone, Brain, Heart (BBH) study, both WLH and women at risk for HIV (WRH)
had a significantly higher burden of both traditional CVD risk factors and psycho-social risk factors compared to
an independent control population of age- and sex-matched women, recruited from the same geographical
area into the Center for Health Discovery and Wellbeing (CHDWB). They also had a greater than expected
prevalence of sub-clinical CVD measured as endothelial dysfunction and coronary atherosclerosis that were
measured using coronary CT angiography and calcification. We also found that circulating progenitor cell
(CPC) levels, a measure of endogenous regenerative capacity, were higher in WLH compared CHDWB
controls, demonstrating stimulation of bone marrow regenerative activity by HIV. However, lower CPC counts
were associated with the presence of coronary atherosclerosis in WLH.
Because these cross-sectional relationships suggest, but do not confirm, causal links between potential
mechanisms including (i) gut barrier impairment/dysbiosis-mediated inflammation to premature CVD in WLH,
(ii) changes in regenerative capacity, and (iii) psycho-social stress risk factor burden, in our renewal
application, we propose to investigate whether progression of sub-clinical CVD over a 5-year period is greater
in WLH. We will leverage the already recruited age- and race-matched population from CHDWB as controls.
We will explore whether such progression is moderated by a) HIV and/or estrogen deficiency induced gut
disruption and the associated immune dysregulation (Aim 1), b) reduced endogenous regenerative capacity
(Aim 2), and c) psycho-social factors (Aim 3). Because CVD is higher in WLH and also in women following
menopausal transition, our overarching goal is to investigate the extent to which HIV and/or estrogen
deficiency impact on the gut co-act to mediate the factors driving the high burden of CVD in WLH especially
during the period of menopausal transition.

Public health relevance
Project Narrative: Project 3 (Heart) Women living with HIV (WLH) have a higher risk of developing heart disease at an earlier age and have worse outcomes compared to those without HIV. This increased risk may be due to a combination of a higher burden of cardiovascular risk factors and psycho-social stress in a setting of early menopause, estrogen deficiency and inflammation. Heart disease can also progress rapidly in the setting of reduced regenerative or reparative capacity. In the second phase of this SCORE Bone, Brain, Heart study, we propose to measure progression of peripheral vascular function and coronary artery disease over a 5-year period in WLH compared to a control population of women whose risk for HIV is no higher than found in the general population of Atlanta, GA. We will investigate if the greater susceptibility to heart disease in WLH is due to psychosocial stressors, abnormal regenerative capacity, and/or a leaky gut that promotes inflammation.